BIOCHEMICAL MODEL REACTIONS

Work on artificial enzymes will be pursued. This will include optimizing the substrates for cyclodextrin reactions to achieve maximal accelerations and inclusion of additional binding interactions. Ribonuclease mimics will be developed further, both those based on cyclodextrin and new macrocyclic systems. Lysozyme mimics will be constructed based on cyclodextrin; these have the advantage of rigid placement of catalytic groups. Pyridoxal and pyridoxamine based catalysts will be used to mimic the transaminases and other coenzyme B6 enzymes. Stereoselective synthesis of amino acids by such systems is of particular interest. Enzyme mimics will also be examined for carbon-carbon bond forming synthetic reactions, as with tryptophan synthetase and in Diels-Alder reactions. Polysubstituted steroids, carrying binding and catalytic groups, will be prepared as enzyme mimics also.